CT-Based Modeling of Bone Micro-Architecture and Fracture-Risk in COPD

This translational study seeks to establish a Chronic Obstructive Pulmonary Disease (COPD)-specific fracture
prediction model using our unique computed tomography (CT)-based assessment of peripheral bone micro-
architecture. Osteoporosis, a common comorbidity among patients with COPD, accelerates morbidity and
mortality. The basis for this comorbidity is poorly understood, thus the need for characterizing the link between
COPD-related factors and bone micro-architecture and their association to fracture-risk. Multiple COPD-related
factors are associated with osteoporosis. Different COPD-related causes of bone loss may non-uniformly impact
cortical and trabecular bone structures with varying mechanical consequences, reflective of divergent COPD-
associated fracture-risk in individuals with similar bone mineral density (BMD). Little is known about this linkage,
and our goal is to fill this knowledge gap using a clinically suitable emerging CT-based tool for characterization
of bone micro-architecture at peripheral sites. Specifically, this study will—(1) establish the generalizability of our
bone micro-architecture assessment applied to emerging low dose / high resolution CT scanners from different
vendors; (2) assess its potential as compared to dual energy x-ray absorptiometry (DXA) to explain prevalent
fractures and predict incident fractures among patients with COPD; (3) quantify the impact of different COPD-
related factors on bone structures and their implications for fracture-risk; (4) identify COPD subtypes with rapid
bone structural degeneration; and (5) develop a COPD-specific model for assessment of fracture-risk using
patient-specific data. We will take advantage of—(1) existing COPD patient cohorts with lung characterization at
the University of Iowa (UI) and Columbia University (CU) representing a wide demographic range; (2) access to
emerging CT scanners at both sites; and (3) unique image processing methodologies for quantifying three-
dimensional bone structural metrics. We will recruit 470 COPD patients from the UI and CU cohorts and 80 age-
sex-similar never-smoker controls. At baseline and 3-year follow-up visits, we will collect—(1) data related to risk
factors; (2) a lateral spine CT scout scan to assess vertebral fractures; (3) high resolution CT scans of the ankle
and wrist for computation of bone structural metrics; and (4) whole-body, spine and hip DXA. Siemens Force CT
scanners will be used for all participants except for 100 randomly-selected patients and controls from the UI
cohort who, instead, will be imaged via a Toshiba Aquilion ONE 320 scanner. This study will establish an
emerging CT-based scanner-independent generalizable tool to assess bone response to different therapeutic
interventions aimed at slowing or reversing bone loss, and possibly restoring bone structure, potentially leading
to more patient-specific interventions. Also, this study seeks to explain the relationships among various COPD-
related factors, bone structural changes and their implications for fracture-risk. Finally, a COPD-specific model
for assessment of fracture-risk will be developed that will utilize patient-specific demographic, clinical and
radiographic data, and CT BMD at the spine, as well as bone structural measures at the wrist and/or ankle.

Public health relevance
The goal of this translational study is to establish a newly emerging CT-based tool for the characterization of changes in bone micro-architecture and assessment of their implications for fracture-risk in a population of COPD patients at risk for osteoporosis. The tool will be suitable and generalizable across emerging CT scanners from different vendors, and it will provide a more structurally-based assessment of osteoporosis and bone loss than is provided by simple bone density measures. The study will characterize the impact of different COPD-related factors on bone structure, and their implications for fracture-risk, leading to the development of a COPD-specific model for assessment of fracture-risk that will utilize patient-specific demographic, clinical and radiographic data, and CT BMD at the spine, as well as bone structural measures at the wrist and/or ankle.